Iron homeostasis and monocyte differentiation in patients with chronic kidney disease

PROJECT SUMMARY
Chronic kidney disease (CKD) affects 10% of the population worldwide. More than 37 million people are
estimated to have CKD in the US, and 2 in every 1000 Americans need dialysis or a kidney transplant to survive.
CKD has numerous systemic complications including anemia and dysfunctional systemic iron homeostasis.
Kidney fibrosis is the final mechanism common for all progressive kidney disorders. Unfortunately, very few
therapies are available to slow the progression of kidney fibrosis in patients with CKD. Kidney macrophages are
one of the key cells implicated in the pathophysiology of kidney fibrosis. The majority of kidney macrophages
originate from circulating monocytes. In his K08-funded project Dr. Akchurin elucidated the pathologic role of
depletion of labile iron pool in kidney macrophages in propagation of kidney fibrosis. This R03 proposal will
enhance his capabilities of deciphering the role of iron in pathologic behavior of myeloid cells in CKD by now, in
addition to kidney macrophages focusing on their precursors, circulating monocytes. Based on the preliminary
data, the central hypothesis of this proposal is that in patients with CKD, circulating monocytes, similar to kidney
macrophages, exhibit pathologically depleted intracellular labile iron pool LIP, which alters their phenotype by
inducing CX3CR1 and other receptors facilitating chemotaxis and tissue invasion. Repletion of this intracellular
monocyte labile iron pool through correction of systemic iron imbalance will be associated with reduction of this
pro-inflammatory differentiation. This hypothesis will be tested in two specific aims: (1) determine the intracellular
iron status of classical, intermediate, and non-classical circulating monocytes in patients with CKD and (2)
elucidate the role of systemic and intracellular iron status in the differentiation of monocytes in patients with CKD.
To test this hypothesis, the applicant will use the existing repository of peripheral blood mononuclear cells
collected from children with CKD with and without functional or absolute iron deficiency and from healthy control
children. He will evaluate these cells using single cell transcriptomic and multicolor flow cytometry approaches
with the focus on delineating the phenotypic features responsible for subsequent tissue invasion, such as
expression relevant chemokine receptors, including CX3CR1. Furthermore, he will perform ex vivo evaluation of
human monocytes collected from CKD patients to directly assess their relevant functional characteristics in the
presence and absence of iron stimulation. Monocyte functional characteristics will be analyzed I the context of
clinical parameters, levels of circulating and urine-excreted chemokines, and systemic parameters of iron
homeostasis. Results
techniques
an
kidney
from t he outlined experiments will provide preliminary data, as well as experience in
for the functional ex-vivo testing of uman monocytes, to support the K08 awardee's application for
R01 proposal to evaluate the impact of iron metabolism and iron therapy on myeloid cells in the context of
fibrosis and CKD progression.
h

Public health relevance
PROJECT NARRATIVE This study will elucidate how disrupted iron homeostasis is related to the function of circulating monocytes, precursors of kidney macrophages, in patients with chronic kidney disease. Kidney macrophages, most of which originate from circulating monocytes, are critically important in progression of kidney fibrosis, the final common mechanism of all individual progressive kidney disorders leading to chronic kidney disease; and at the same time macrophages play critical role in iron metabolism, which is severely altered in chronic kidney disease. By addressing the critical knowledge gap about the connection between iron metabolism and differentiation of circulating monocytes as they invade injured kidney tissue and become macrophages, this project will enhance the capabilities of the primary investigator in attaining his long-term goal of identifying novel actionable drivers of chronic kidney disease progression due to alterations in iron homeostasis, so that they can be therapeutically targeted to improve outcomes in patients with chronic kidney disease.